TOPIC 022 - TECHNOLOGICAL DEVELOPMENT AND VALIDATION OF REMOTE MEASURES FORUSE IN CLINICAL TRIALS IN INDIVIDUALS WITH RARE DISEASES

There is a present need for development of novel means for assessing and monitoring research participants remotely. In research on rare diseases, the population of interest is likely
geographically dispersed and already burdened by ongoing care for their disease. It is not always practical, reasonable, or economical to recruit and retain participants when asking them to access research locations that may be far away and inconvenient. Technology enabling remote and virtual participation in trials will enable researchers to include participants that otherwise would have been excluded from participation. In this Phase I project, the Orthocare Innovations team will develop an integrated hardware, software, and data access platform for remote patient assessment, called StepWatch Remote.